Leveraging Implementation Science to Promote Behavior Change and Reduce Cancer Health Disparities among American Indian and Alaska Native Older Adults

Project Summary
American Indian and Alaska Native (AIAN) adults are more likely to develop cancer and die from it than white
American adults, reflecting pronounced and persistent cancer health disparities (CHDs). Colorectal cancer
(CRC) rates are disproportionately high among AIANs in the Northern Plains and Alaska regions; likewise, risk
factors for CRC are also high, including non-modifiable factors such as increasing age and rurality, and proven
modifiable risk factors such as physical inactivity, and obesity. A recent consensus report indicates strong
evidence that physical activity (PA) lowers risk for colon cancer through systemic (i.e., metabolism,
inflammation) and obesity reduction pathways. However, despite availability of efficacious behavioral
interventions to increase PA among older adults, a critical gap exists between evidence generated and action
taken to implement such interventions among AIAN older adults. This gap represents a missed opportunity to
implement current evidence-based interventions (EBIs) in cancer prevention among high-risk populations
experiencing pronounced CHDs. Implementation science concentrates on understanding and accelerating
integration of such EBIs into public health practice settings to improve health and can be leveraged here to
address this critical public health gap, thus addressing persistent CHDs and improving overall health among
AIAN communities. This F99/K00 Predoctoral to Postdoctoral Fellow Transition Award application assists a
promising trainee - Maja Pedersen, who has 15 years of experience in community-based behavioral
interventions among rural AIAN communities in the Northern Plains and Alaska regions - to embark on a
rigorous research and training program to confront this critical gap using best practices for intervention
research with AIAN communities and current implementation science methods. Pedersen’s long-term goal is to
become an independent investigator in designing and implementing PA interventions among underserved
populations - including AIANs - to improve cancer-related health outcomes and reduce CHDs. Her short-term
goals include gaining expertise in the use of multilevel intervention methods, dissemination and implementation
science, cancer prevention and control among geriatric populations, experimental design, and intensive
longitudinal methods. In collaboration with her multidisciplinary team of predoctoral mentors, she has
developed a training plan to initiate these goals via coursework, workshops, scientific meetings, directed
readings, and mentored research (F99 Phase). As she transitions into the postdoctoral phase, she will
assemble a team of high-level, cancer-focused mentors to support her through continued mentored training
with an explicit focus on cancer prevention and control. Her postdoctoral research (K00 Phase) executes the
logical next steps in her research sequence on a trajectory toward a full-scale implementation and
effectiveness trial as an independent scientist.

Public health relevance
Project Narrative The proposed research reduces modifiable risk factors to prevent colorectal cancer among American Indian and Alaska Native (AIAN) older adults, who experience pronounced cancer health disparities (CHDs). Results contribute to a growing field of implementation science to address CHDs and follows landmark efforts to align with ethical, strengths-based practices for public health research with AIAN communities. At completion of the proposed aims, the trainee will transition into early-career investigator stage equipped with the expertise, experience, and networks to successfully launch an independent research career focusing on behavioral interventions to reduce CHDs among diverse, geriatric populations.